FLUORESCENT NANODIAMONDS FOR IN VITRO AND IN VIVO BIOLOGICAL IMAGING-SBIR TOPIC 8

The purpose of Phase I isto develop a biocompatible fluorescent label that never photobleaches or blinks, and that is brighter than commonly used dyes.